Viral In-depth Characterization Through Immunocapture to Identify the Cellular Sources and Genetic Diversity of the HIV-1 Reservoirs

PROJECT SUMMARY
Despite the remarkable success of antiretroviral therapy (ART) to control HIV-1 infection, viral reservoirs
persist indefinitely under treatment. These remaining viral populations constitute the principal burden for an
effective HIV-1 cure, as they lead to a rapid “rebound” in viremia when treatment fails or is discontinued. Viral
reservoirs in ART treated individuals are constituted by latently infected long-lived immune cells. Additionally,
the reservoir comprises populations that produce low levels of viremia even in presence of high levels of ART.
The sources of this residual viremia might play a key role in the fast “viral rebound” often observed after
therapy cessation. Different studies demonstrate that the reservoirs are rapidly established early after infection
and distributed throughout the body in multiple anatomical sites. In addition to T-CD4+ cells, a growing number
of studies suggest that other T-cells and myeloid cells such as macrophages and mast cells constitute potential
active and/or inducible reservoirs too. This capacity to establish reservoirs in a wide variety of cellular targets
and anatomical compartments is promoted by HIV-1 accessory and regulatory proteins and might lead to viral
characteristics directly associated with the producer cell type. In this proposal, we aim to characterize viruses
produced by different cell types and their corresponding integrated provirus using tissue “ex vivo” infections.
Furthermore, we will study the sources and characteristics of the viral particles that comprise the residual
viremia from various anatomical compartments using clinical samples from people living with HIV-1 under ART.
We will use our newly developed pipeline that combines viral immuno-capture (v-IC) from multiple cell types,
with proviral sequencing in the same cell types, long-read deep viral sequencing, and viral particle multi-omics.
This new pipeline will be very relevant for HIV-1 cure studies to identify the sources of viremia during ART and
to better analyze the viral reservoirs.

Public health relevance
Project Narrative HIV-1 reservoirs that persist indefinitely under ART are constituted by viral populations established in multiple immune cell types. We will deploy a viral-immunocapture, cell isolation, and viral long-read deep sequencing pipeline combined with transcriptomics and proteomics validation of purified viral particles to fully characterize the virus produced by the main HIV-target cells in tissues. We will apply this approach to study the origin of residual viremia during ART in clinical samples.